NEW PHYSICAL METHODOLOGIES FOR GENOMIC ANALYSIS

DESCRIPTION: An approach to acquiring DNA sequence data is proposed that involves the imaging of single DNA molecules. Specific or random priming sites throughout the molecules will be tested for their ability to have a fluorescent nucleotide added by a polymerase. An imaging system will detect the single fluorochromes and document the next base in the sequence series for each site. Potential acquisition of 20 Kb of DNA sequence data contained within 10-40 digital images is described. The proposed potential rate of sequence acquisition is 180 Kb per hr. A similar approach to detecting single base polymorphisms is proposed that does not require directly detecting a single molecule, but instead tests whether multiple labeled nucleotides are added to a site that may or may not terminate with a dideoxynucleotide. A plan to map and subclone BACs as a paradigm for eventual DNA sequencing is proposed. A plan to improve charge density on glass surfaces as a way to optimize DNA fixation for optical mapping is also proposed.